Administrative Core

PROJECT SUMMARY – CORE A
The COBRE Center of Molecular Analysis of Disease Pathways at the University of Kansas is overseen,
operated, guided and driven by its Administrative Core. Dr. Susan Lunte has led the Center in Phase 1 and 2
and will continue to be the PI and Director in Phase 3. She will be assisted by an Associate Director, the CMADP
Program Manager, a Financial Analyst and an Award Coordinator. A Steering Committee consisting of Core Lab
Directors, Scientific Advisors and Institutional Officials will also assist and advise the Director regarding Core
Lab needs and Pilot Project selections. The CMADP External Advisory Committee is comprised of three
internationally recognized experts in different aspects of molecular analysis of disease pathways that are related
to our three Core Labs. The EAC will provide advice and guidance to the Director and CMADP leadership
regarding Core sustainability, Pilot Project selection, research and career progress of project investigators, and
overall Center administration. The Administrative Core will be responsible for implementing and overseeing the
Pilot Projects Program, career and research guidance activities, and the three continuing and highly successful
Core Laboratories in addition to providing overall leadership for the Center.